Defining the Role of MAT2A in Alcohol Use Disorder

PROJECT SUMMARY
Alcohol use disorder (AUD) is a chronic condition characterized by persistent neuroadaptive changes that
drive alcohol-seeking and consumption. Emerging research highlights the crucial role of epigenetic regulation
and chromatin remodeling in addiction, particularly through histone methylation. Alcohol exposure increases
trimethylation of histone 3 at lysine 4 (H3K4me3) in hippocampal neurons, an activating mark associated with
gene transcription. However, the underlying mechanisms of these epigenetic changes remain unclear,
particularly the role of metabolic pathways that provide the central cofactor and methyl-group donor required
for histone methylation: S-adenosylmethionine (SAM). This project aims to elucidate the role of methionine
adenosyltransferase 2A (MAT2A), the enzyme in the methionine cycle that produces SAM, in alcohol-induced
histone methylation and subsequent gene regulation. We hypothesize that MAT2A interacts with specific
genomic loci in hippocampal neurons, influencing local H3K4me3 states upon alcohol exposure, leading to
disrupted gene regulatory events and further alcohol-seeking behavior. Preliminary data suggests that MAT2A
translocates to the nucleus of neurons in response to chemical stimulation. In Aim 1, I will determine MAT2A
subcellular localization changes during alcohol exposure using subcellular fractionation combined with western
blotting, immunofluorescence, and ChIP-sequencing. This will provide insight into how alcohol influences the
movement and expression of MAT2A within the cell and its potential interactions with chromatin. In Aim 2, I will
assess the necessity of MAT2A for alcohol-induced H3K4me3 by knocking down MAT2A using viral vectors.
Additionally, I will test whether the SAM-producing function of MAT2A drives these changes by supplementing
with SAM after MAT2A knockdown. Finally, Aim 3 will strive to connect these molecular events to behavioral
outcomes. I will evaluate the impact of MAT2A knockdown on alcohol-consumption behavior in a voluntary
binge-drinking model, using the 2-bottle-choice drinking-in-the-dark paradigm. Together, this research will
uncover critical molecular mechanisms of alcohol exposure in the brain, exploring the intersection of
epigenetics and metabolic enzymes. Our findings may identify novel therapeutic targets for alcohol use
disorder, potentially offering new avenues for treatment and prevention strategies.

Public health relevance
PROJECT NARRATIVE Alcohol use disorder (AUD) is a chronic brain condition that severely impacts the lives of affected individuals and their families, imposing a tremendous societal burden due to the limited efficacy of current treatments. This proposal investigates the intersection of metabolic and epigenetic regulation in brain function, with a specific focus on the methionine cycle enzyme MAT2A. By elucidating the role of MAT2A in these processes, this research aims to uncover novel targets and develop innovative therapeutic strategies, ultimately improving treatment options and outcomes for individuals suffering from AUD.